Impacts of Urbanization on Vector Biology and Transmission of Dengue in China

Project Summary
Title: Impacts of Urbanization on Vector Biology and
Transmission of Dengue in China
Dengue fever is an acute infectious disease caused by the dengue virus and
transmitted by Aedes mosquitoes. Despite the intense control program in China, major
dengue outbreaks have recently occurred in the urban area of Southern China. Control
of mosquito populations is the only available strategy for prevention of dengue because
there are no effective drugs for dengue. The use of chemical insecticides represents the
most important element of vector control for dengue in China and worldwide. Our
preliminary data indicates a rapid rise of pyrethroid resistance in the dengue vectors in
urban areas of southern China. This competing renewal application will test the
central hypothesis that frequent dengue outbreaks and intensive insecticide use
in the urban environment lead to an emergence and spread of insecticide
resistance in the dengue vector, which in turn increases vector population
density and vectorial capacity for dengue. We proposed three interlinked specific
aims: 1) to determine resistance level of dengue vector populations in urban and rural
environments, 2) to develop new molecular tools for insecticide resistance surveillance
through a better understanding of resistance mechanisms, and to conduct molecular
surveillance of insecticide resistance in urban and rural environments, and 3) to
determine the effect of insecticide resistance on mosquito survivorship, vector
competence and vectorial capacity in urban and rural environments. We will focus on
Aedes albopictus, a highly invasive species and the most important dengue vector in
Southern China. The knowledge and tools from this project will help in guiding the
selection of insecticides for dengue vector control, facilitate insecticide resistance
surveillance and management, and enhance our understanding of dengue epidemiology
in the urban environment where insecticide resistance is rapidly increasing.

Public health relevance
Relevance to Public Health: Insecticide-based control of mosquito vectors is the most important method for dengue prevention, but the emergence and rapid spread of insecticide resistance have significantly hampered the success of the vector control programs in China and worldwide. This project will examine the impact of insecticide resistance on dengue transmission, and develop new tools for insecticide resistance detection. The tools from this will greatly facilitate insecticide resistance management of dengue vectors.